COCHLEAR MECHANICS, WAVE PROPAGATION, AND COMPRESSION

PROJECT SUMMARY/ABSTRACT
COCHLEAR MECHANICS, WAVE PROPAGATION, AND COMPRESSION
The proposed project continues a program of research that is improving our knowledge of cochlear
function through a combination of theoretical and empirical studies of fundamental processes in the peripheral
auditory system that have both basic and translational implications. The first aim addresses a theoretical issue
concerning power amplification in cochlear mechanics. It posits a mechanism for amplification in a four-
chamber cochlear model and investigates consistency with experimental observations. This aim tests
supporting evidence for the existence of a hypothetical cochlear amplifier. The second aim focuses on further
development of a method for measurement of acoustic emissions from the inner ear that are evoked by wide-
band noise stimuli. Signal processing and statistical analysis of these cochlear-reflectance measurements will
improve their sensitivity to hearing loss and improve the accuracy of their prediction of hearing threshold. The
remaining two aims of this project both utilize a cochlear-processing simulation, which is based on an existing
nonlinear model of cochlear mechanics. Through a combination of computational modeling and behavioral
measurements these aims will investigate two perceptual phenomena: consonant recognition and loudness
growth. These aims will both test the hypothesis that cochlear processing produces spectro-temporal features
that are closer to observed perception than features derived directly from the acoustic signal. Through efforts
related to all four aims, questions that possess both basic scientific interest and applied clinical relevance will
be addressed by combined application of measurement and modeling efforts.

Public health relevance
PROJECT NARRATIVE The cochlea is the part of the inner ear that responds to sounds and is the primary organ for our sense of hearing. The proposed research program will develop a computational simulation of cochlear mechanics that addresses a fundamental question regarding amplification in the cochlea. In addition, results from cochlear models will be combined with physiological and behavioral data from human subjects to support the investigation of specific auditory phenomena, such as acoustic reflections from the cochlea, speech-consonant perception, and multi-tone loudness growth. Thus, the proposed research combines human measurements and computer simulations to address important questions about hearing processes that have both basic scientific and applied clinical relevance.